GROWTH RETARDATION--HPA AXIS RESPONSE TO CRH AND CORTISOL CHALLENGES

This proposal studies the growth hormone (GH) and hypothalamic pituitary adrenal (HPA) axis physiology in children with short stature and psychosocial dwarfs. The aim is to address the possibility that: repeated psychological stress during development activates the HPA axis; leads to an abnormal regulation of its elements and this ultimately is conducive to a tonic inhibition on GH release and growth failure.